Developing Human Pluripotent Stem Cell Tools for Region-Specific Pain Circuits

PROJECT SUMMARY/ABSTRACT
Species-specific differences and the complexity of cellular interactions involved in human pain perception have
created challenges relying on conventional preclinical rodent models or simple human pluripotent stem cell
(hPSC)-derived nociceptor models for novel drug development. Pain signaling pathways comprise of multiple
neuronal, glial, and immune cell types within the peripheral (PNS) and central nervous systems (CNS), but the
contributions of these cells in pain sensation is still under investigation. Moreover, these cells and the circuits
they form exhibit region-specific characteristics, with unique positional identities along the body axis, and
require a three-dimensional (3D) microenvironment with component parts—including end-organ tissues— to
establish appropriate connectivity, plasticity, excitability, and functionality.
Recognizing these challenges, the goal of this project is to bridge the gap by developing advanced
stem cell tools to facilitate the creation of comprehensive and region-specific models for studying
afferent pain circuitry. Building upon established technologies for region-specific spinal cord differentiation
within my lab, this project will pursue three main objectives. Objective 1 involves developing scalable and
systematic methods to generate region-specific sensory neurons and glial subtypes. Objective 2 focuses on
creating and characterizing region-specific somatosensory organoids that faithfully mimic the in vivo
microenvironment. Objective 3 aims to integrate hPSC-derived pain circuits into two tissue-engineered models
for women's health—breast cancer metastasis and endometriosis— to determine how region- and subtype-
specificity impacts innervation in the context of health and disease.
Altogether, we will produce a suite of region-specific cells, circuits, and tissues that will deepen our
understanding of the unique pain networks along the body axis and expedite the development of model
systems for high-throughput screening of targeted analgesics. Furthermore, as a new investigator with
multidisciplinary interests, this New Innovator Award will advance technologies in our lab that can be applied
beyond pain research to a broad range of applications in neurological diseases, tissue engineering, and
regenerative medicine.

Public health relevance
PROJECT NARRATIVE Neither conventional preclinical models using rodents nor simple human stem cell models using pain-sensing nociceptors capture the complexity of human pain circuits. This hampers the discovery of solutions for treatment of chronic pain, which may potentially target multiple cell types (including both neurons and supporting glia), localized cell populations with distinct positional identities and/or the environment where these pain networks reside. This proposal will develop advanced human stem cell tools that will establish region- specific cells, circuits, and tissues, enhancing our fundamental understanding of human pain networks along the body axis and accelerating the creation of accurate models that can be used for high throughput drug screening.